The Lung PCA: A Multi-Dimensional Atlas of Pulmonary Premalignancy

In this proposal, that enhances ongoing Lung PCA studies, we propose aims to examine the protein localization, cell type specific expression, and biological pathways up-regulated with key SARS-CoV-2 viral entry genes across the various stages of lung cancer development. We will compare these results with protein expression of key SARS-CoV-2 viral entry genes as well as immune, epithelial, and endothelial cell proteins in lung tissue from patients that died from COVID-19, and from lung tissue sampled pre- and post-COVID-19 disease. Spatially characterizing the epithelium and stromal microenvironment and expression of key SARS-CoV-2 entry genes during the development of lung cancer in the central airway and the alveoli may identify potential ways to improve clinical management of this high-risk patient population and improve COVID-19 outcomes

Public health relevance
Project Narrative from Overall Component of Original Proposal: Lung cancer is the leading cause of cancer deaths worldwide, in large part due to the difficulty in detecting cancer at its earliest stage and the lack of effective approaches to prevent lung cancer in those at highest risk. We will build a high-resolution atlas characterizing the earliest cellular and molecular alterations in pre-cancerous lesions of the airway and lung, providing new opportunities for early cancer detection and novel targets to intercept the development of lung cancer.